Traumatic Brain Injury, Social Relationships, and Risk of Dementia

PROJECT SUMMARY/ABSTRACT
Traumatic Brain Injury (TBI) is a significant public health concern, particularly among older individuals, and TBI
affects everyone in an individual’s social network, not just the individual with the injury. Studies have shown that
family members, particularly ones who take on the role of caregivers, may experience feelings of burden,
psychological distress, anxiety and depression, and decreased quality of life. It is well demonstrated that TBI is
a significant risk factor for Alzheimer’s disease and related dementias (ADRDs), and TBI is designated as one
of fourteen potentially modifiable risk factors for dementia by the 2024 Lancet Commission on Dementia, along
with social isolation. Cognitively stimulating activities, including social engagement, are also potentially
modifiable and have been shown to be protective against dementia and mortality among older adults. However,
the impact of interpersonal factors (e.g., social relationships) with respect to associations of TBI with dementia
and mortality risk is not well-understood, particularly with consideration of potential differences by sex. Further,
the impact of TBI on spouses/caregivers with respect to dementia and mortality risk is not clear. Examining
neurodegenerative biomarkers in the context of TBI and social engagement has the potential to elucidate
mechanisms underlying associations with dementia. This F32 application aligns squarely with NIA priority areas:
1) understanding the dynamics of aging via the effects of interpersonal factors, and 2) improving our
understanding of the aging brain and ADRD, to inform interventions and policy. The overarching goal of this
proposal is to examine the role of social relationships with respect to dementia risk both in the context of an
aging individual with TBI and among spouses (as a surrogate for caregivers) of individuals who sustain a TBI.
Aim 1 will investigate if measures of mid-life social engagement modify the association of later life TBI with
dementia and neurodegenerative ADRD biomarker trajectories, and differences by sex. Aim 2 will evaluate
whether an individual’s risk of dementia and neurodegenerative ADRD biomarker trajectories is associated with
a spousal TBI event, further assessing differences by the occurrence of spouse mortality after TBI and by sex.
This F32 will also support excellent professional and personal training opportunities for Dr. D’Alonzo in
aging/dementia and the use of plasma biomarker and neuroimaging data in the context of epidemiologic studies
under the guidance of an interdisciplinary team of expert mentors. The research and training plan will prepare
her to become an independent investigator and aging/injury epidemiologist, implementing novel statistical
methods focused on TBI across the life course and long-term cognitive and ADRD-relevant outcomes in older
adults.

Public health relevance
PROJECT NARRATIVE Traumatic brain injury (TBI) affects everyone in an individual’s social network and represents a significant, modifiable risk factor for Alzheimer’s disease and related dementias (ADRDs) along with social isolation, but the impact of interpersonal factors (e.g., social relationships) on associations of TBI with dementia risk is unclear. The overarching goal of this proposal is to examine the role of social relationships with respect to dementia risk and ADRD-related biomarker trajectories both in the context of an aging individual with TBI and among spouses (as a surrogate for caregivers) of individuals who sustain a TBI. The overall hypotheses are that greater mid-life social engagement will attenuate associations of TBI with risk of later-life dementia, and that spouses of individuals who suffer a TBI will have increased risk of dementia; further, these associations will differ by sex.